Project 1: Adjuvanted Protein Vaccines for Pandemic Preparedness

Project Summary/Abstract - Project 1: Adjuvanted Protein Vaccines for Pandemic Preparedness
In preparation for possible future pandemics, our goals for Project 1 are to characterize immune responses and
to develop new adjuvanted multivalent recombinant protein vaccines that are cross-protective within these
target priority virus families with pandemic risk. We will interact closely with other Projects/Cores in the UCI
ReVAMPP program. Each year we will supply Projects 3-5 and Translational Immunology Core with lead
protein vaccine formulations for rodent and non-human primate immunity and challenge models and
transitional human studies, as well as provide a protein microarray for antibody profiling in serum samples from
all projects in the ReVAMPP programs. We will also support Project 2 on formulation and characterization of
mRNA LNP candidates with various lipids, and collaborate with the Regulatory Science Core to ensure the
work performed in this project meets the standards of a quality system allowing the rapid transfer of the
recombinant protein vaccine technologies for their production and further IND-enabling studies. We propose
five Specific Aims: (1) Adjuvant formulation and characterization for recombinant protein vaccines against
Bunyaviruses, Paramyxoviruses and Picornaviruses (2) Immunoprofiling of multivalent recombinant protein
vaccine formulations in rodents via i.m.; (3) To develop the process for the production of six recombinant
protein vaccine antigen candidates against Bunyavirales, Paramyxoviridae, and Picornaviridae. (4) Protein
vaccines for systemic and mucosal immunity. (5) Breadth/durability of multivalent protein vaccine formulations.